Interdependency of chemical, structural, and physiological heterogeneity in Pseudomonas aeruginosa biofilms

PROJECT SUMMARY
Bacterial infections constitute a major burden on healthcare systems globally. One of the reasons these
diseases are difficult to treat is that most antibiotics act specifically on rapidly growing cells, but bacteria in
many types of infections grow slowly and exist in static aggregates. Our long-term goal is to define the
integrated molecular pathways that support survival of bacteria in aggregates that contain chemical gradients,
with a focus on the opportunistic pathogen Pseudomonas aeruginosa. To investigate multicellular physiology
and spatial organization, we employ standardized models in which aggregates are grown suspended in a
supplied polymer matrix, or at interfaces with air where they produce their own matrix and form structures
called biofilms. The main hypothesis driving our work is that cells in developing aggregates respond to, and
affect the distribution of, metabolic cues that affect physiological differentiation, and that these activities support
population robustness and survival in infection sites. This project will focus on P. aeruginosa lactate
metabolism and self-resistance to cyanide (a P. aeruginosa virulence factor) because the associated pathways
contribute to bacterial survival and multicellular physiology. We will use basic molecular approaches combined
with newly developed and innovative techniques, including imaging mass spectrometry and live microscopic
analysis of biofilms, to address questions regarding the modulation of metabolic pathways in response to
chemical cues and an endogenous toxin, the regulation of spatial patterning at the cellular level, and the effects
of microanatomy on biofilm physiology: (1) How do biofilm and infection-site conditions and co-occurring
bacteria affect P. aeruginosa’s use of lactate, a major carbon source available within hosts? (2) How does P.
aeruginosa tolerate its own production of cyanide? (3) How is cellular organization established, and what are
the consequences of cell patterning for metabolic differentiation within biofilms? As P. aeruginosa is a major
cause of infections in hospitals, in burn and surgical-site wounds, and in patients with cystic fibrosis, we are
motivated by the potential for these mechanisms to serve as therapeutic targets.

Public health relevance
PROJECT NARRATIVE Bacteria commonly form dense multicellular structures, such as biofilms, during host infection and this behavior increases their resilience and prolongs disease. We study the mechanisms that allow multicellular bacteria (1) to obtain energy from substrates and protect themselves from self-produced toxins in infectious environments, and (2) to form organized arrangements that influence the distribution of resources and drugs across the population. This work will uncover potential targets for treatment and may reveal basic aspects of multicellular physiology that are relevant for many types of bacteria.